Stroke Minimization through Additive Anti-atherosclerotic Agents in Routine Treatment II Study

Global estimates suggest that sub-Saharan Africa (SSA) now has the highest incidence and prevalence of stroke
and the worst survival outcomes from stroke in the world. Current projections are that the already overwhelming
burden of strokes and other cardiovascular diseases (CVDs) in Africa will continue to escalate over the coming
decades as traditional vascular risk factors burgeon in these populations. Indeed, hypertension and dyslipidemia
are the top 2 modifiable risk factors for stroke in Africa with population attributable fractions of 90.2% and 35.8%,
respectively, positioning them as prime targets for secondary risk reduction after stroke. Identifying strategies to
reduce vascular risk in Low-and Middle-Income Countries (LMICs) will meet a global goal of reducing chronic
disease death rates by an additional 2% per year, with only a moderate rise in health expenditures. Ghana is a
LMIC in SSA with a profound lack of human resources for health care coordination for stroke survivors, especially
in the implementation of evidence-based secondary prevention therapies. Fixed-dose combination pills, also
known as “polypills”, containing generic drugs: aspirin, a statin, and blood pressure (BP) lowering medication(s),
may be a viable low-cost avenue to broadly improve medication adherence and consequently reduce further
disability or death on a large scale among stroke survivors in SSA. Therefore, the overall objective of Stroke
Minimization through Additive Anti-atherosclerotic agents in Routine Treatment II (SMAART-II) study is to deploy
a hybrid study design to 1) demonstrate the efficacy of a polypill (Polycap ®) containing fixed doses of
antihypertensives, a statin, and antiplatelet therapy taken as two capsules, once daily orally in reducing
composite vascular risk over 24 months vs. usual care among 500 recent stroke patients encountered at 12
hospitals in Ghana; 2) develop an implementation strategy for routine integration and policy adoption of Polypill
for post-stroke cardiovascular risk reduction in an under-resourced system burdened by suboptimal care and
outcomes. SMAART-II is premised on the feasibility and relative safety of the Polycap ® for ischemic stroke
among Ghanaians in a single center trial (SMAART-I) conducted with the support of an R21 grant (NS103752)
from the NIH Global Brain Disorders program. We now seek to test the definitive efficacy and safety of the polypill
to improve meaningful post-stroke global risk factor control in a larger sample, across several sites, across
diverse health care settings, beyond tertiary level care, and over a longer period. In addition to assessing clinical
outcomes, SMAART II will assess implementation outcomes such as adoption, acceptability, cost, pertinent to
uptake of the Polypill strategy in Ghana to inform policy. Regardless of its outcome, findings from SMAART-II
will contribute meaningful information from the African perspective to inform the formulation of guidelines for
global adoption of polypills into routine care for secondary CVD risk prevention by international bodies such as
the World Health Organization.

Public health relevance
Our objective for this research is to determine the efficacy of the polypill (one pill that contains fixed doses of antihypertensives, statin and aspirin) compared with usual care in reducing overall vascular risk among recent Ghanaian stroke survivors over 24 months. Participants in this trial will be enrolled from 12 hospitals including primary, district/regional, and tertiary levels across 6 regions (states) in Ghana to broadly capture patient and clinician experiences with the polypill and enhance the generalization of study findings. We also seek to develop an implementation strategy using a consultative, multi-stake holder engagement for routine integration and policy adoption of the polypill as a viable approach for post-stroke cardiovascular risk reduction in a resource-limited setting.